Institutional Career Development Core

Contact PD/PI: Kern, Philip A. Inst-Career-Dev-001 (002) PROJECT SUMMARY ? KL2 INSTITUTIONAL CAREER DEVELOPMENT The University of Kentucky Center for Clinical and Translational Science (CCTS) proposes to sustain and enhance the current KL2 program, currently in its ninth year of National Institutes of Health (NIH) support. By providing two to three years of release time (75% effort) and research funding support for mentored career development, the program is designed to accelerate the academic growth for the next generation of leaders in clinical and translational research (CTR). The program has four programmatic objectives: 1) to provide a curriculum that meets core training needs of CTR scholars, 2) to support a mentored program of research training that expedites development of research careers, 3) to support personalized training programs that expedite CTR career development, and 4) to provide continuous assessment and quality improvement of both individual scholar career development and overall KL2 program. The program has garnered strong institutional support; across the nine years, the initial two NIH-supported training slots have been expanded to seven slots (four NIH-supported, three institutionally supported). The program supports career development of scholars with research interests that cross the lifespan (prenatal through elderly) and the full spectrum of clinical and translational science, including translational, clinical, community/policy studies and clinical and translational research (CTR) methods/processes (e.g., biomedical informatics) focusing on a broad array of health topics. Scholars and mentors represent a wide range of disciplines and colleges including Medicine, Nursing, Dentistry, Pharmacy, Health Sciences, Public Health, Education, Engineering and Arts and Sciences. All program graduates (n=18) remain actively engaged in CTR, have made important contributions to science through published research and have successfully competed for extramural funding with 14 as principal investigators. We are requesting renewed NIH support of four KL2 scholar training slots. The training of a minimum of three additional institutionally sponsored early-career scholars will continue to be fully integrated with these NIH-supported scholars to sustain a cohort of at least seven scholars. The foundation of the proposed program will continue to be practical research experiences within multidisciplinary teams guided by experienced mentors, with a Faculty Oversight Committee monitoring the successful career development of these future CTR leaders. Educational technology promotes vigorous yet efficient competency training programs. Further, our enhanced team science training programs will focus specifically on developing leadership skills. Institutionally sponsored pipeline programs targeting undergraduates, medical students, residents, fellows and clinical instructors, several focused on underrepresented minorities, will support the availability of a strong and diverse pool of candidates for the KL2 program. In sum, the KL2 program is accelerating the career development of future leaders of the biomedical research workforce who are well prepared to address today’s complex research challenges and spearhead future advances in human health. Project Summary/Abstract Page 863 Contact PD/PI: Kern, Philip A. Inst-Career-Dev-001 (002) BIBLIOGRAPHY AND REFERENCES CITED 1. Kelly TH, Mattacola CG. Training and career development in clinical and translational science: An opportunity for rehabilitation scientists. J Sport Rehabil 19:369-379, 2010. 2. Jones C, Parmentier, Sonstein S, Silva H, Lubejko, Pidd, Gladson, Browning. Defining competencies in clinical research: Issues in clinical research education. Res Practitioner 3:99-107, 2012. 3. Miyaoka A, Spiegelman M, Raue K, Frechtling J. Findings from the CTSA national education and training study. Rockville, MD: Westat; 2011. 4. Sonstein S, Silva H, Seltzer J, Li R, Jones C, Daemen E. Moving from compliance to competency: A harmonized core competency framework for the clinical research professional. J Clin Res Best Practices 10:1-11, 2014. 5. Yin HL, Gabrilove J, Jackson R, Sweeney C, Fair AM, Toto R, Clinical, Translational Science Award Mentored to Independent Investigator Working Group C. Sustaining the clinical and translational research workforce: Training and empowering the next generation of investigators. Acad Med 90:861-865, 2015. PMCID: PMC4587496 6. Begg MD, Bennett LM, Cicutto L, Gadlin H, Moss M, Tentler J, Schoenbaum E. Graduate education for the future: New models and methods for the clinical and translational workforce. Clin Transl Sci 8:787-792, 2015. PMCID: PMC4709034 7. National Research Council Committee on Bridges to Independence: Identifying Opportunities f, Challenges to Fostering the Independence of Young Investigators in the Life S. The National Academies Collection: Reports funded by National Institutes of Health. In: Bridges to Independence: Fostering the Independence of New Investigators in Biomedical Research. (Eds). National Academies Press (US) National Academy of Sciences.; Washington (DC). 2005 8. Alberts B, Kirschner MW, Tilghman S, Varmus H. Rescuing US biomedical research from its systemic flaws. Proc Natl Acad Sci U S A 111:5773-5777, 2014. PMCID: PMC4000813 9. Daye D, Patel CB, Ahn J, Nguyen FT. Challenges and opportunities for reinvigorating the physician- scientist pipeline. J Clin Invest 125:883-887, 2015. PMCID: PMC4362227 10. Sweeney C, Schwartz LS, Toto R, Merchant C, Fair AS, Gabrilove JL, Group CM-t-IITW. Transition to independence: Characteristics and outcomes of mentored career development (KL2) scholars at clinical and translational science award institutions. Acad Med 92:556-562, 2017. PMCID: PMC5373479 11. Areephanthu CJ, Bole R, Stratton T, Kelly TH, Starnes CP, Sawaya BP. Impact of professional student mentored research fellowship on medical education and academic medicine career path. Clin Transl Sci 8:479-483, 2015. PMCID: PMC4626384 12. Solomon SS, Tom SC, Pichert J, Wasserman D, Powers AC. Impact of medical student research in the development of physician-scientists. J Investig Med 51:149-156, 2003. 13. Robertson CM, Klingensmith ME, Coopersmith CM. Long-term outcomes of performing a postdoctoral research fellowship during general surgery residency. Ann Surg 245:516-523, 2007. PMCID: PMC1877044 14. Garrison HH, Deschamps AM. NIH research funding and early career physician scientists: Continuing challenges in the 21st century. FASEB J 28:1049-1058, 2014. PMCID: PMC3929670 15. Nearing KA, Hunt C, Presley JH, Nuechterlein BM, Moss M, Manson SM. Solving the puzzle of recruitment and retention-strategies for building a robust clinical and translational research workforce. Clin Transl Sci 8:563-567, 2015. PMCID: PMC4626410 16. Schneider M, Guerrero L, Jones LB, Tong G, Ireland C, Dumbauld J, Rainwater J. Developing the translational research workforce: A pilot study of common metrics for evaluating the Clinical and Translational Award KL2 Program. Clin Transl Sci 8:662-667, 2015. PMCID: PMC4703562 17. Ley TJ, Rosenberg LE. The physician-scientist career pipeline in 2005: Build it, and they will come. JAMA 294:1343-1351, 2005. 18. Feldman AM. The National Institutes of Health Physician-Scientist Workforce Working Group report: A roadmap for preserving the physician-scientist. Clin Transl Sci 7:289-290, 2014. PMCID: PMC5439807 19. Lee A, Dennis C, Campbell P. Nature's guide for mentors. Nature 447:791-797, 2007. 20. Pfund C, House SC, Asquith P, Fleming MF, Buhr KA, Burnham EL, Eichenberger Gilmore JM, Huskins WC, McGee R, Schurr K, Shapiro ED, Spencer KC, Sorkness CA. Training mentors of clinical and translational research scholars: A randomized controlled trial. Acad Med 89:774-782, 2014. PMCID: PMC4121731 References Cited Page 864